Flow Cytometry Core

PROJECT SUMMARY
FLOW CYTOMETRY CORE
The Flow Cytometry Core (FCC) has been a Moffitt Cancer Center-supported Shared Resource Facility since
1990 and provides centralized and cutting-edge flow cytometry services for Moffitt’s cancer-related research.
FCC is conveniently accessible to Members at all hours and with on-site assistance during working hours. The
overarching goal of FCC is to support Members and trainees with highly skilled personnel and state-of-the-art
technical assistance in high-throughput and multi-dimensional flow cytometry acquisition and cell sorting. FCC
activities supporting this goal are organized intro three Specific Aims:
Aim 1: To deliver expert assistance in experimental design and analysis.
Aim 2: To provide state-of-the-art flow cytometry services.
Aim 3: To provide training and education.
FCC is staffed with a well-established Scientific Director and immunology expert, Dr. Paulo C. Rodriguez, and a
team of highly experienced technologists, who collectively have more than 65 years of research-based practice
in flow cytometry. Since the last competitive renewal, FCC expanded on its strengths, and added and upgraded
its instrumentation. Current FCC services include: 1) Accurate detection and analysis of multiple parameters at
the single-cell level; 2) Ability to rapidly purify target populations, to assess specific cellular functions, and to
molecularly characterize purified cell populations; 3) Assistance in experimental design, data analysis and
interpretation; and 4) Delivery of expert training and education in flow cytometry technologies.
Notably, FCC support has contributed to multiple high impact translational research projects at Moffitt. Over the
last five years, FCC usage increased by 51%, which resulted in 120 peer-reviewed publications, with 30 in high
impact journals. Moreover, FCC trained 130 research staff and trainees, and maintained an excellent member
satisfaction rate – over 90% – each year. Over the last fiscal year (FY20), FCC supported 61 Members in four
of the five Programs (CBE 25%, CE 3%, MM 36%, IO 36%), with 75% of those Members holding peer review
funding. This accounted for 98% of all FCC usage. In the next cycle, FCC will continue supporting all CCSG
Programs and further expand its services based on the growing flow cytometry needs of Moffitt Members.
Future FCC priorities are to expand its technical and consultation services in multi-parametric single-cell
analysis, high-speed cell sorting, and big-data flow cytometry workflow processes. To address these needs, FCC
will acquire a new fast-speed cell sorter as well as a spectral-based cytometer that provides up to 40+ parameter
flow cytometry. Finally, FCC will expand its repertoire of education and training initiatives and will develop a Flow
Cytometry Interest Group that discusses publications, ongoing projects, and latest approaches in flow cytometry.